MECHANISM OF ACTION OF ANTI-TUMOR DRUGS

We have found that the ansa macrolide maytansine, which is a competitive inhibitor of vinblastine for binding to tubulin, has different effects on the conformation of the tubulin molecule than does vinblasatine. Vinblastine quenches the intrinsic fluorescence of tubulin bi-phasically whereas maytansine does so mono-phasically. Maytansine enhances the alkylation of tubulin by (14C)iodoacetamide whereas vinblastine suppresses the alkylation of tubulin. We intend to do the following experiments. We want to examine the effect of maytansine on the circular dichroism spectrum of tubulin and to use electron microscopy to analyze maytansine-induced microtubule disassembly to see the nature of the intermediates. We will also analyze the direction of maytansine-induced disassembly using outer doublet seeds and pulse-labeled microtubules. We hope to determine inhibition constants for maytansine's blocking of microtubule assembly with tau and HMW 2 and to isolate and identify the peptide or peptides which contain the sulfhydryls whose alkylation maytansine enhances. We will also compare the effects of maytansine and its analogue ansamitocin P-3.